Administrative Core

PROJECT SUMMARY (See instructions): The Administrative Core will provide centralized professional and administrative support to the Program and its Investigators. This includes overall monitoring of progress, organization of weekly meetings of research personnel, facilitation of communications among the units involved on the project, and coordination of the activities of the advisory committees.

Public health relevance
The administrative core provides support to Project and Core directed toward studies of pulmonary surface liquid, seeking an understanding of how the lung confronts environmental stresses and how the lung fails in diseases of pulmonary surface liquid depletion or excess. This understanding should reveal novel therapeutic strategies to address major human lung diseases, including cystic fibrosis, COPD, and ARDS.